TERT transcriptional deregulation in thyroid cancer progression

PROJECT SUMMARY / ABSTRACT
TERT transcriptional deregulation in thyroid cancer progression
I trained in thyroid cancer genetics in my graduate studies, during which time I identified germline promoter
variants conferring thyroid cancer susceptibility. In my postdoctoral years I led a project that revealed the key
somatic genomic and transcriptomic hallmarks of poorly differentiated (PDTC) and anaplastic (ATC) thyroid
cancers. We reported that mutations in the promoter of TERT (telomerase reverse transcriptase) gene are the
most prevalent genetic alterations in often fatal PDTCs and ATCs, and constitute good biomarkers of disease
severity. Although it is widely accepted that TERT promoter mutations activate gene transcription, the specific
mechanisms and biological effects of these alterations remain largely unknown. This prompted me to study the
role of TERT transcriptional deregulation in thyroid cancer progression, which is the subject of my K22 proposal.
I believe this project has great potential and will facilitate my setting up my own lab. To this end, I have put
together an advisory committee and collaborators who will share their expertise and resources in the fields of
transcriptional regulation, chromatin biology and genetically engineered mouse models of cancer, as well as
career advice, while I seek to secure a tenure-track position. This proposal outlines a comprehensive approach
to characterizing the role of TERT promoter mutations in telomerase transcriptional deregulation and thyroid
cancer progression. The first aim of this project is to identify the transcriptional complex that differentially binds
TERT mutant vs. wildtype promoter, and to this end I propose a dual regulation model. First, we describe
experiments to define the role of specific ETS family members in TERT mutant promoter reactivation, which we
believe are distinct from those reported in other disease contexts. We will also evaluate the effect of MAPK
constitutive signaling, a hallmark of thyroid tumors, in ETS-mediated TERT expression. Second, we aim to unveil
the influence of the CTCF genome insulator on TERT transcriptional repression through long-range enhancer-
promoter interactions. We have preliminary data suggesting that ETS and CTCF factors compete for TERT
promoter binding in mutant and wildtype conditions, respectively, inducing opposite effects on gene transcription.
Our second aim is to characterize the first Tert mutant promoter mouse model, which we have already generated
via CRISPR knock-in of the equivalent mouse locus. Our preliminary data suggest that Tert promotes thyroid
cancer progression in combination with a thyroid-specific oncogenic BrafV600E allele. We will also assess which
signaling pathways are involved in Tert-induced thyroid tumors, and whether they create unique vulnerabilities
that can be exploited therapeutically. Overall, my goal is to establish myself as an independent investigator in
the field of thyroid cancer biology and transcriptional regulation, and the awarding of the K22 grant will greatly
facilitate this transition.

Public health relevance
PROJECT NARRATIVE Telomerase reverse transcriptase (encoded by TERT) is an enzyme known to extend the survival of cells, and it is reactivated in approximately 90% of human tumors. We recently identified TERT promoter mutations as the most frequent genetic alterations in advanced thyroid cancers, which generally respond poorly to traditional treatments and contribute to a significant proportion of deaths caused by this disease, and showed that they are likely central events in thyroid cancer progression. We aim to understand TERT transcriptional deregulation and, taking advantage of a novel Tert promoter-mutant mouse model that we generated, to explore its biological consequences and therapeutic opportunities in vivo.